Regulation of OATP1B1 and OATP1B3 by lysine acetylation and lysine deacetylase inhibitors

The goal of this application is to request funding to purchase the Jess System from ProteinSimple
for automated quantitative protein analysis. The Jess system is a capillary-based Western system
that is gel free and blot free and which fully automates loading, size-based protein separation,
data analysis and antibody probing, washing and detection. The Jess System executes protein
analysis with high sensitivity, exceptional reproducibility, accurate protein quantification and rapid
and high-throughput capabilities. Incorporating the Jess System into my research will improve my
research program, enhance the Rigor and Reproducibility for studies outlined in the parental R01
award. Additionally, the Jess System will facilitate adherence to the data sharing policy of NIH.

Public health relevance
Significance to Public Health Organic anion transporting polypeptides OATP1B1 and OATP1B3 mediate the uptake of many drugs and endogenous compounds from blood into the liver. The proposed research will elucidate novel regulatory mechanisms that modulate the function of these important liver-specific transport proteins. Such information is essential to predict clinically relevant drug-drug and drug-disease interactions.